The Role of Thromboxane A2 in Vascular Regulation in Women with Endometriosis

Project Summary
CVD is the leading cause of death worldwide. Endometriosis has been repeatedly identified as an independent
risk factor for CVD that affects an estimated one in ten women in the world. Endometriosis is a gynecologic
condition characterized by invasive extrauterine endometriotic lesions, chronic pain and pain sensitization, and
systemic inflammation and is associated with accelerated cardiovascular disease risk. The expression of
cyclooxygenase-2, a key enzyme in inflammation, is upregulated in endometriotic lesions as are its metabolites,
namely TxA2. TxA2 is a potent vasoconstrictor able to diffuse across the endothelium to act directly on its
receptors in the vascular smooth muscle. TxA2 can also antagonize NOS within the endothelial cells, preventing
vasodilation. A decrease in nitric oxide (NO)-mediated vasodilation defines endothelial dysfunction and is
regarded as a critical early event in the development of atherosclerosis and overt cardiovascular disease.
Women with endometriosis demonstrate marked endothelial dysfunction compared with healthy controls.
Furthermore, TxA2 receptors (TP) play a key role in sensitizing the sensory afferents in skeletal muscle in pre-
clinical models of cardiovascular disease, leading to an exaggerated exercise pressor reflex. This is a strong
predictor of major adverse cardiovascular events in cardiovascular disease patients. Therefore, the purpose of
this project is twofold: 1) to determine the effect of the TP on the regulation of microvascular function and in
circulating platelets in women with endometriosis and 2) to investigate sensory afferent sensitization in women
with endometriosis. We hypothesize that women with endometriosis demonstrate exaggerated vasoconstriction
to both pharmacological stimuli locally modulating vasomotor tone and to physiological sympathoexcitatory
stimuli. This project and associated training plan will serve as a vehicle for exceptional predoctoral training for
the candidate.

Public health relevance
Project Narrative Endometriosis increases the risk of cardiovascular disease, and before this, impairs endothelial function. Women with endometriosis demonstrate increased expression of thromboxane A2 a substance which directly induces vasoconstriction, is an antagonist of nitric oxide synthase activity, and sensitizes sensory afferents in pre-clinical models of cardiovascular disease. The proposed research will determine the role of thromboxane A2 in the regulation of vascular tone in women with endometriosis, providing information that can be directly translated to the development of preventive interventions in this population.